Core 1: Resource for AcademIc SuccEss (RAISE)

ABSTRACT
The Resource for AcademIc SuccEss (RAISE) Core is a Shared Resource, available to support all
Partnership participants. The RAISE Core will have two areas of emphasis: individualized career support for
Early Stage and New Investigators (ESIs/NIs) and serving as the Ombudsperson for all participants.
The Core will act as a foundation that supports the individuals that make up the Partnership. The RAISE Core
Leads have a extensive and complementary experience that allows them to act as coaches and advisors and
identify appropriate resources to support Partnership faculty and staff. By providing individualized support for
ESIs/NIs, the Core will directly address needs and knowledge gaps to enable faculty to increase their cancer
research capability, become more effective collaborators and enhance their research on cancer health
disparities. Regular individual meetings with ESIs/NIs will allow RAISE to provide advice, information, and
access to professional development activities in a safe setting and timely manner. At any time, ESIs/NIs may
request resources and/or activities for career growth. Such resources may include course release time for
manuscript or proposal preparation, registration and travel for a focused professional development workshop
and faculty coaching.
The heart of the Partnership is training and research collaborations between New Mexico State University and
Fred Hutchinson Cancer Center. The Ombuds can serve to strengthen and improve collaborations and
mentee-mentor relationships by facilitating communication to reveal differing expectations and work toward
agreement of shared expectations. This increases cancer research capability because time in conflict is
minimized and time and focus on research and education is maximized. This in conjunction with individualized
faculty mentoring creates an environment that encourages the professional development of faculty and
supports their engagement with the Partnership’s Guiding Principles (see Overall).